Prediction and Word Learning in Young Children with Autism Spectrum Disorder

ABSTRACT
Current estimates suggest that autism spectrum disorder (ASD) impacts 1 in 44 children in the United States.
Many young children with ASD demonstrate language delays, which are often the first area of concern noted by
their parents. Young children with ASD show markedly different word learning profiles than their neurotypical
(NT) peers, characterized primarily by atypical or delayed use of word learning mechanisms. We currently have
an incomplete understanding of these differences. Discerning the mechanisms that underlie language learning
deficits in ASD will afford greater success in alleviating these difficulties and supporting language learning in this
population. One theoretical account, a predictive impairment in autism (PIA) hypothesis, has shown promise for
explaining some phenotypic characteristics of ASD (i.e., difficulty making social predictions). The utility of this
theoretical framework for explaining difficulty with language learning, however, remains largely unclear. Autistic
children show intact statistical word learning abilities on experimental tasks. However, given that children learn
words in their natural, often unpredictable environments, difficulty tracking unpredictable stimuli might have
profound impacts on autistic children’s word learning. The overall objective of the proposed project is to
determine how established, domain-general difficulties with prediction in ASD might impact novel word learning.
This project will employ established eyegaze methodology to test the impact of predictable and unpredictable
presentations on word learning in this population. The central hypothesis is that unpredictable contexts during
training will disproportionately disrupt word learning in children with ASD and result in disproportionate detriments
to the retention and generalization of object-label pairings. Preliminary data suggest that autistic children are
disproportionately disrupted by unpredictable input in a fast-mapping task. Guided by the PIA hypothesis and
this strong preliminary data, the proposed project will address three specific aims. Specific Aim I will characterize
the impact of predictable and unpredictable presentations of novel-word object pairings on initial word learning
(fast-mapping) in autistic toddlers compared to cognitively matched NT peers. Specific Aim II will investigate the
impact of predictability during initial learning on autistic toddlers’ retention and generalization of word-object
pairings over a short (5-minute) delay, compared to NT peers. Specific Aim III will evaluate the extent to which
child characteristics (e.g., language and cognitive abilities) predict individual variability in word learning
performance following predictable and unpredictable input in autistic children. The proposed project will be the
first to apply established eyegaze methodology to test this theoretical framework and its application to initial word
learning, retention, and generalization in this population. The proposed project’s significance is that it will
advance theories of autism and our understanding of language learning in this population. The proposed project’s
impact is that findings will inform best practices and novel treatment strategies that allow for optimal language
learning for autistic children.

Public health relevance
PROJECT NARRATIVE The proposed project will be the first to investigate the impact of predictability of the word learning environment on fast-mapping, retention, and generalization of newly learned words in young children with ASD compared to cognitively matched NT peers. This project will employ two brief eyegaze experiments which will evaluate performance on a word-learning task in which words will be taught in both predictable and unpredictable sequences and tested as they appeared in training immediately (fast-mapping) and after a 5-minute delay (retention) as well as for generalization to shape-matched objects. Finally, individual differences (e.g., extant language and cognitive abilities) associated with greater disruption of learning from unpredictable stimuli will be investigated.